Data Management Core B

REVISED SUMMARY – CORE B
The Data and Analytics Core (Core B) is responsible for the comprehensive ADRD- specific data management and analytic support required to design and execute these projects. To meet these goals, Core B will create: (1) a comprehensive database with sufficient power to characterize detailed patterns of healthcare utilization, (2) a broad array of measures drawn from diverse sources that can augment these data, (3) the analytic capacity, expertise, and oversight to ensure timely, high-quality design and execution of analyses and creation of analytic datasets, and (4) appropriate access to these resources for other investigators including common definitions of ADRD, data repository of coded qualitative data, and a legacy plan to ensure that the data curation is easily understood, accessed, and documented for future research. The specific aims of Core B are: (1) To maintain a comprehensive and secure database of administrative data including Medicare and Medicaid enrollment files, claims records, supplementary files, as well as qualitative data as identified by each Project Leader; (2) To create shared resources and measures—including ADRD cohort definitions, code libraries, and interview guides—for use across all projects; (3) To provide study design, data collection, and data analysis technical support and analyst effort for quantitative and qualitative aims across all four projects; and (4) In coordination with Core A, to make the research files developed under this PPG available to the broader research and policy community, and to facilitate data triangulation across the four projects. All four projects will interact with Core B in four ways. First, the projects will be responsible for developing and testing new measures and methods that then become part of Core B’s repository for production and dissemination among the investigators. Second, each project will use analytic datasets and data collection, management, and analytic support created through Core B personnel. A major enhancement to this renewal is the introduction of qualitative and mixed-methods data management and analytic support to build upon existing methods (based on Medicare claims) and link to newer resources developed under this renewal. Third, the leadership of Core B will be responsible for fostering a collaborative environment in which analysts and investigators continue to work seamlessly to generate data and research of the highest caliber. Finally, because of Core B’s involvement in all four projects, personnel will be able to leverage early- phase methods and findings to help inform questions or triangulate with data collected in later phases across all projects.